Dynamic Variable Aqueous Humor Outflow and Glaucoma Therapies in the Human Eye

Project Summary
Glaucoma is a leading cause of permanent vision loss worldwide, and the only treatment is to lower intraocular
pressure (IOP). IOP is governed by how aqueous humor (the fluid in the eye) exits the drainage pathways that
start at the trabecular meshwork (TM) before moving into Schlemm’s canal, collector channels, an intrascleral
venous plexus, and aqueous/episcleral veins. However, recent discoveries have demonstrated that aqueous
humor outflow (AHO) is not static and unchanging but is more complex than a simple linear depiction. AHO
shows dynamic variable behavior (or dynamic variable outflow; DVO) where it is variable with segmental
regions of the eye displaying high- or low-AHO, is dynamic where AHO can spontaneously increase or
decrease in different locations of the eye, and is improvable where drugs or surgeries can enhance it. Thus,
this proposal aims to better study DVO by uncovering how and why AHO can be improved in certain regions of
the eye. This helps understand what may have been lost in disease and what may be targeted in IOP-lowering
treatments. The central hypothesis in this proposal is that glaucoma therapies work at improvable DVO
regions and that by facilitating DVO research and knowing where and how this occurs, personalized glaucoma
treatments can be crafted for individual patients. To accomplish this, we will utilize cutting edge structural
imaging tools such as anterior segment optical coherence tomography (OCT). We will also use a method
called aqueous angiography that we developed on a previous National Institutes of Health and National Eye
Institute grant. Aqueous angiography allows researchers to see exactly where aqueous humor is flowing in the
eye in a real-time fashion. With these tools, we will study ex vivo human eyes in the laboratory and in donor in
vivo eyes to yield the most germane discoveries for glaucoma and glaucoma treatment. In Specific Aim (SA1),
we will discover how DVO is regulated by studying the structural and molecular basis of segmental and
dynamic AHO using imaging and screen-based tools on human donor and ex vivo eyes in the laboratory. In
SA2, we will use ex vivo human eyes to study how glaucoma surgeries in different locations in the eye impact
IOP lowering and what hurdles the proximal vs. distal AHO pathways present to surgical success. In SA3, we
will investigate how glaucoma pharmacological drugs (currently FDA-approved drug formulations and delivery)
alter DVO in ex vivo and donor eyes, specifically looking at the parts of the eye that are improved by treatment
to understand why these areas had the capacity to do so. Through the results of this proposal, we will better
understand the dynamic processes of how intraocular fluid leaves the eye as a way to enhance current
glaucoma treatments and to create a springboard to innovate new ones.

Public health relevance
Project Narrative Glaucoma is a leading cause of permanent vision loss in the United States and worldwide where the only treatment is to lower intraocular pressure (IOP). IOP is largely governed by how aqueous humor (the fluid in the eye) exits through drainage pathways; and recent discoveries have uncovered that aqueous humor outflow (AHO) is not static and unchanging but instead shows previously unappreciated behaviors such as dynamic variable outflow (DVO): including dynamic, segmental, and rescuable characteristics. Specifically, in this proposal we work to 1) discover the regulation of DVO and study how glaucoma 2) surgeries and 3) pharmacological drugs alter or are impacted by DVO in different parts of the eye as a way to improve current treatments and help innovate future ones.